AIDS Malignancy Consortium (AMC) - International Protocol Development Support

Abstract/Lay Summary
The AIDS Malignancy Consortium (AMC) was established in 1995 and has been at the forefront
of the clinical evaluation of interventions for the treatment and prevention of malignancies in
people living with the human immunodeficiency virus (PLWH). The consortium includes 10
international trial sites located in 6 countries in sub-Saharan Africa (including 6 sites in South
Africa, Kenya, Zimbabwe, Uganda, and Malawi) and Latin America (including 4 sites in Mexico,
Brazil, and Argentina). The supplement to the AMC grant (2UM1CA121947) will support
convening an expert group of scientific reviewers to provide peer review of approximately 2-4
AMC clinical trials annually that will involve patient accrual from the 10 AMC international sites.

Public health relevance
Narrative Cancer has been recognized as occurring more commonly in people living with human immunodeficiency virus infection (PLWH), and remains a leading cause of morbidity and mortality despite improvements in antiretroviral therapy. The spectrum of these cancers in PLWH is diverse, complex, and challenging to prevent and treat. AMC remains the only organization worldwide solely dedicated to the study, treatment and prevention of cancer in PLWH.